Adaptive immunity to Aspergillus during neutropenia

PROJECT SUMMARY/ABSTRACT
Aspergillus species are ubiquitous molds that cause clinical disease in hosts with impaired immunity or
abnormal mucosal defenses. In particular, individuals with neutropenia or neutrophil defects are particularly
susceptible to invasive pulmonary aspergillosis (IPA), a life-threatening respiratory infection with limited
treatment options. Neutrophils play a key role in host defenses against this pathogen but little is known about
the contribution of these cells beyond their direct microbicidal role. This project examines how neutrophils
influence the development of adaptive immunity to Aspergillus in order to better understand mechanisms of host
immunity to Aspergillus during neutropenia. In the preliminary data for this proposal, we report that neutrophil-
depleted mice have an exaggerated IL-17A response compared to neutrophil-sufficient mice after Aspergillus.
We show that following challenge with Aspergillus, IL-17A-producing CD4+ tissue resident memory (TRM) cells
persist in the lung up to three weeks after challenge in neutrophil-depleted mice, and that mice that were
neutrophil-depleted during a primary Aspergillus challenge are protected from a secondary challenge with
Aspergillus when compared to mice that were neutrophil-sufficient during primary challenge. We therefore seek
to test the central hypothesis that, in the absence of neutrophils, Aspergillus induces an exuberant IL-17
response which leads to the persistence of IL-17A-producing CD4+ tissue resident memory cells, and that these
cells confer protection against subsequent infection with Aspergillus. To test this hypothesis, we plan to pursue
the following specific aims: Aim 1: Determine if CD4+ tissue resident memory lymphocytes protect against
Aspergillus infection during neutropenia and Aim 2: Identify pathways involved in neutrophil-independent IL-
17A-mediated protection during rechallenge with Aspergillus. The project brings an innovative approach to the
study of this infection through the use of a dual challenge model of IPA which mimics repeated exposure to this
fungal pathogen in human hosts and the characterization of a novel and previously undescribed protective role
for TRM in the setting of neutrophil-depletion. The proposed studies are relevant to public health by defining a
new mechanism of host defense against an important human pathogen that should allow for future development
of novel therapeutics or preventative strategies.

Public health relevance
PROJECT NARRATIVE Aspergillus is a common environmental fungus that can cause invasive pulmonary aspergillosis, a dangerous infection in patients with weakened immunity. We seek to understand the components of the immune system that help the body fend off this infection. This knowledge has the potential to lead to new treatments to protect patients from this devastating infection.